Imaging Core - NINDS Institutional Core Grants to Support Neuroscience Research

Facilities and Services. This Core provides the infrastructure and experienced staff to support the MR scanning needs of neuroscientists using NHPs in their research. The Core is built around a head-only, 3T Siemens Allegra Magnetic Resonance scanner that has been optimized for brain imaging.